Indigenous Trauma & Resilience Research Center- Administrative Core

ADMINISTRATIVE CORE PROJECT ABSTRACT
The purpose of the Administrative Core is to ensure that the infrastructure, support mechanisms, and
processes of the COBRE facilitate the development of early career investigators. The Administrative Core is
comprised of: (1) Dr. Donald Warne, Program Director/Principal Investigator (PD/PI); (2) an Internal Advisory
Committee (IAC); (3) an External Advisory Committee (EAC); (4) Senior Management Advisor; (5)
Biostatistician; and (6) a team of superb individual project mentors. The Administrative Core leadership team
has extensive experience in mentoring early career investigators and in administering large scale research
enterprises across multiple disciplines.
Objectives
1. Ensure the long-term success of the Indigenous Trauma & Resilience Research Center by establishing and
supporting a thematic, multidisciplinary center that focuses on Indigenous trauma and resilience research.
2. Develop and implement a Research Training and Career Development Plan to support COBRE individual
research Project Leaders (PLs) that leads to independent investigator status.
3. Establish a pilot study program that ensures development of faculty in the Center.
4. Implement an Evaluation Strategy and Milestones to track progress and to ensure objectives are met.
Methods: Mentoring and Faculty Development activities will also include: Colloquium Series in Indigenous
Health Disparities; Research Seminars; Monthly Meetings; Administrative Meetings; Annual American Indian
(AI) Health Research Conference; and Pilot projects that will promote career development within the scientific
theme and will assist in determining the next round of junior investigator PLs. These activities will be available
to the broader UND community and will assist in expanding the knowledge base and skillsets of the entire
campus. These events will also provide a mechanism to recruit additional junior investigators and pilot projects
to replace those who move on to independent investigator status. Evaluation will include formative and
summative evaluation strategies. Key milestones and timelines to ensure appropriate career development of
junior investigators include application to an externally funded Research Project Grant (RPG) by the end of
year 2 of COBRE support, and Independent Investigator status by the end of Year 3. Evaluation will also
assess how well the cores are meeting the needs of the PLs.